Provider and Survivor Perspectives on Screening for Intimate Partner Violence During Pregnancy and Postpartum

PROJECT ABSTRACT
Homicide is a leading cause of death among women who are pregnant and within 1 year
postpartum in the US. A majority of cases involve intimate partner violence (IPV), which is
known to escalate during pregnancy. Our overall objective is to understand, from the
perspective of health care providers and survivors of violence, barriers and preferences for
increasing IPV screening and supports in maternity care settings. This information will inform
the future development and implementation of a multi-level intervention to build capacity and
improve provider and system-level responses in the care of pregnant and postpartum women
experiencing IPV. Our specific aims are (1) To identify specific barriers to and preferences for
IPV screening and responding as perceived by health care providers, and (2) To obtain in-depth
understanding of the preferences around screening and responses to IPV as perceived
survivors of violence during pregnancy and postpartum. Our approach involves the convening of
focus groups comprised of health care providers who may come in contact with pregnant and
postpartum people (including OB/GYNs, advanced practice registered nurses, pediatricians,
midwives, doulas, lactation consultants, and emergency department practitioners) as well as
persons who experienced violence during pregnancy or the postpartum period. We will use
Nominal Group Technique, a structured idea-generating process that produces quantitative
weights to a breadth of issues that were obtained through a qualitative, discussion-based
approach. Findings from this work will include a comprehensive view of reasons underlying the
consistently low rates of identification and responding to IPV among pregnant and partum
people among a diverse group of providers who are mostly likely to encounter this population.
Of critical importance, this work will center the voice of those with lived experience and provide
a detailed characterization of how best to identify and support pregnant IPV survivors in health
care settings, by their own account.

Public health relevance
PROJECT NARRATIVE Homicide is a leading cause of death during pregnancy and postpartum in the US. This project seeks to optimize health care settings as critical windows of opportunity to identify and respond to pregnant and postpartum women experiencing intimate partner violence that may lead to homicide. Finding from this study – informed by both health care providers and survivors of violence during pregnancy and postpartum – will help to establish effective and efficient practices, policies, and procedures that can protect the health and safety of women during pregnancy and beyond.